CHOP Pediatric Scholars Program

K12 Abstract
The Children's Hospital of Philadelphia (CHOP) Child Health Research Career Development Award
(CHRCDA) K12 Training Program is intended to foster the maturation of pediatric junior faculty into
independent physician-scientists who are skilled in cutting-edge methods of laboratory research and who
pursue long-term academic careers investigating important issues related to childhood health and disease. The
CHOP CHRCDA Program is based on a pool of outstanding candidates, a large group of experienced mentors
who perform state-of-the-art laboratory research, a robust research environment, and a comprehensive array
of career development opportunities. The Principal Investigator/Program Director and the Training Director will
receive assistance from two Diversity Recruitment Officers, an Internal Advisory Committee, and an External
Advisory Committee in selecting scholars, reviewing the progress of scholars, and ensuring the optimal
operation of the program. Three scholars will be supported each year and will be drawn from junior faculty in
the Department of Pediatrics, with particular emphasis on recruitment of women, underrepresented minorities,
individuals with disabilities, and other disadvantaged individuals. The Program Faculty mentors have been
drawn from the Department of Pediatrics, the Department of Pathology, and the Department of Surgery at
CHOP and from a range of clinical and basic science departments at the University of Pennsylvania (Penn).
The Program Faculty have been selected based on a strong track record in research that is germane to
pediatrics, extramural funding, and mentoring. The CHRCDA Scholars will conduct research as outlined in their
formal research applications and will have access to all shared facilities and to the full spectrum of core
facilities at CHOP and Penn. The CHRCDA Scholars will also benefit from the opportunity to pursue a wide
range of career development activities, including coursework, workshops, and other special educational and
training experiences. The CHOP CHRCDA Program will build on the impressive success of the 27 CHOP
CHRCDA Scholars over the past 15 years and the 63 CHOP CHRCDA Scholars over the past 25 years.

Public health relevance
K12 Narrative The overall goal of this CHRCDA program is to identify, train, and mentor promising pediatric faculty to become successful independent physician-scientists addressing questions of fundamental importance to health and disease in children. The CHOP CHRCDA Program will increase the number and effectiveness of subspecialty pediatricians with rigorous background and skills in basic and translational research. In turn, these individuals will speed the transfer of knowledge gained through studies in basic and translational science to clinical applications that will benefit the health of children.